Development of Human Norovirus Samples for Antiviral Research

To develop standardized, widely available, and growth culture verified norovirus samples that can be used to facilitate antiviral testing.